Pre-analytical variables of bioanalytes affecting the accuracy of PTCL diagnostic and prognostic genetic signatures

Abstract
Peripheral T-cell lymphomas (PTCL) represent approximately 12-15% of all NHL in the western world and are
associated with dismal prognosis. Furthermore, the diagnosis is challenging as 30-50% of PTCL cases cannot be
assigned to a specific entity and are categorized as PTCL-not otherwise specified (PTCL-NOS). We have defined
robust gene expression signatures that can differentiate the five common PTCLs entities: angioimmunoblastic T-cell
lymphoma (AITL), anaplastic lymphoma kinase positive anaplastic large-cell lymphoma (ALK (+) ALCL), ALK-
negative anaplastic large-cell lymphoma (ALK (-) ALCL), adult T-cell leukemia/lymphoma (ATLL), and extra-nodal
natural killer/T-cell lymphoma (ENKTCL). PTCL-NOS can be divided into two distinct biological and prognostic
subgroups (PTCL-TBX21 and PTCL-GATA3 subgroups). We translated the RNA based diagnostic and prognostic
algorithms for formalin fixed paraffin embedded (FFPE) tissues for widespread clinical usage with high sensitivity and
specificity. We also identified distinguishing genetic lesions in PTCL subtypes using corresponding DNA , and
demonstrated that such lesion can be validated using shallow whole genome analysis (sWGA) in corresponding
plasma cell-free DNA, thus liquid biopsy can aid in diagnosis and disease monitoring.
Since the biospecimen processing, and hence quality, varies significantly in routine clinical pathology laboratories,
the reliability of RNA or DNA based signatures need to be evaluated under variable circumstances. It is essential to
determine how the robustness of the assay may be affected by pre-analytical variables before the novel diagnostic
tools can be applied to large studies or routine clinical practice. We hypothesize that a comprehensive evaluation of
pre-analytical variables of biospecimen will lead to optimized bio-specimen procurement framework leading to
improved diagnostic accuracy and reproducibility in tissue and liquid biopsy setting and can be standardized in an
inter-CLIA lab setting for routine clinical practice/trials. This proposal aims to establish standardized, evidence-based
procedures on bio-specimen (RNA/DNA) processing, storage and transportation to ensure accurate, reproducible
assay performance. The identified conditions and parameters will be validated on prospective samples, preferably in a
clinical trial setting, so findings can be correlated with clinical data. Thus, three specific aims are proposed:
Specific Aim 1: To determine pre-analytical variables that affects the reliability of RNA-based assays in
FFPE tissue
Specific Aim 2: To identify pre-analytical factors affecting circulating tumor DNA (ct-DNA) detection and
quantification in patients with PTCL
Specific Aim 3: To validate harmonization of the pre-analytical variables in improving PTCL diagnostic or
prognostic assay in an inter-CLIA (Clinical Laboratory Improvement Amendments) lab setting
The studies will lead to robust protocols that optimize the preservation biomolecules in tissue biopsies or plasma to
ensure accuracy and reproducibility of molecular assays, improving PTCL classification and prognostication.

Public health relevance
Project Narrative Peripheral T-cell lymphoma (PTCL) is a group of heterogeneous disease entities with varied clinico- pathologic features, and ~ 30-50% of PTCL cases remain unclassifiable in current clinical practice. Using novel technological advances, we identified robust molecular classifiers and distinct genetic profiles, which can aid in molecular subclassification of PTCL. We plan to establish standardized, evidence-based procedures on bio- specimen processing for the optimal preservation of bio-analytes to ensure accurate and reproducible downstream assay performance using tissue and liquid biopsy of PTCL.